PSOROSPERMIN AND RELATED ANTITUMOR XANTHONES CHEMISTRY

This project is designed to study the chemistry, stereochemistry, and antitumor activity of the novel antitumor epoxyfuranoxanthone, psorospermin, and other related compounds. Psorospermin shows significant activity over a wide dose range in P388 mouse leukemia, and is also active in a mammary (CD) and colon (C6) tumor system. Specific aims include 1) completion of the structural elucidation of psorospermin by establishment of the absolute configuration of the compound; 2) design and completion of the total synthesis of psorospermin as an alternate source of the compound for further anticancer testing; 3) synthesis and testing of a limited series of related xanthones and acridones in order to establish structure-active relationships in this series. A sufficient amount of psorospermin is urgently needed to complete antitumor testing and other biological studies persuant to consideration for further preclinical evaluation.